FREQUENCY OF RECURRENCE OF GROUP A STREPTOCOCCAL PHARYNGITIS IN CHILDREN

Compare the frequency of recurrent streptococcal pharyngitis in children receiving either immediate or delayed penicillin treatment of a primary epidode of pharyngitis..